Population-level Pulmonary Embolism Outcome Prediction with Imaging and Clinical Data: A Multi-Center Study

Project Summary
Pulmonary embolism (PE) is a leading cause of death in the United States. Risk stratification for acute PE
treatment can reduce mortality. Risk scoring systems use clinical and laboratory electronic medical record
(EMR) data. In addition, biomarkers on computed tomography imaging can identify which patients with PE are
at high risk of death, independent of clinical data. Despite advances in clinical and image-driven scoring
systems, improving outcomes in acute PE depends on implementation of patient-specific EMR and imaging
data analytic prognostic models at the point of care.
The promise of digital medicine stems in part from the hope that by digitizing health data, we can leverage
computer information systems to understand and improve care. A method that can make use of these data to
predict patient-specific outcomes could not only provide major benefits for patient safety and healthcare quality
but also reduce healthcare costs. Unfortunately, most of this information is not yet included in predictive
statistical models that clinicians use to improve care delivery. This is because traditional computational
methods and techniques are insufficient at accurately analyzing such high volumes of heterogeneous data.
The goal of this proposal is to develop an automated precision medicine approach to achieve point-of-care risk
stratification for PE patient outcomes using a fusion deep learning strategy that can simultaneously analyze
health records and imaging data. An ideal PE risk-scoring system would not only predict mortality, but also
assess the risk for the many debilitating long-term consequences of acute PE. Such a system would,
therefore, facilitate optimal management and would likely require intelligent use of clinical, laboratory, and
imaging data together in order to provide accurate patient -specific risk scoring for multiple PE outcome
measures. In order to build a robust model, we propose to apply distributed training of deep learning models
across four large US healthcare institutions. By distributing the algorithm rather than the data, we avoid
sharing individually identifiable patient information. If successful, this project will be the first endeavor to
leverage diagnostic imaging (pixel) data in combination with structured and unstructured EMR data to predict
outcomes.
We have the ideal research team, experience, and methods to develop an automated risk-scoring system for
acute PE patients. Using a powerful combination of clinical, laboratory, and imaging data, this system will
provide patient-specific risk scoring for multiple PE outcome measures. Further, this project will foster multi-
center collaborations, which will afford us the opportunity to investigate the generalizability of our approach to
different populations of PE patients and to train, test, and ultimately deploy our automated predictive model in
a variety of clinical environments.

Public health relevance
Project Narrative Pulmonary embolism (PE) remains a leading cause of death in the United States. This project aims to develop a new ensemble deep learning model and train the model in a distributed fashion on multi-institutional data to automate the risk stratification of PE by integrating diagnostic computed tomography imaging with clinical electronic medical record data. This precision-medicine approach has the potential to rapidly and accurately perform PE risk assessment at the point of care, which could help reduce adverse clinical outcomes and increase our understanding of post-PE complications.